Consortium for Viral Systems Biology Data Management and Bioinformatics Core

Project Summary / Abstract
Our Center seeks to use high-throughput proﬁling technologies to develop predictive models of Lassa fever
and Ebola virus disease at a systems biology level. The success of this mission is dependent on the unique
cohorts and innovative proﬁling methods, the combination of which will result in a unique and powerful data
set. In this context, the overall mission of the Data Management and Bioinformatics Core (DMBC) is to ensure
that the Center utilizes best practices for data provenance, analysis, management, and dissemination
throughout the data lifecycle. To accomplish this mission, we will promote the robust collection and analysis
of the primary data, develop a framework for reproducible workﬂows that can be used across the Center, and
maximize dissemination and reuse of Center-generated data and tools.
Our mission will be accomplished through the completion of three Speciﬁc Aims. Aim 1 focuses on accurately
capturing clinical and laboratory data, and then reproducibly processing them using robust workﬂow tools.
This aim describes a key, foundational function that is critical for the success of the Center. Aim 2 focuses on
dissemination of Center-generated resources according to FAIR principles - Findable, Accessible,
Interoperable, and Reusable. This work will ensure that the impact of our Center extends beyond our team’s
stated analysis plan, and it leverages our extensive work building tools for eﬀective data and software
dissemination. Aim 3 focuses on directly engaging the community in collaborations with a variety of groups
with complementary skills and assets. This work leverages the principle that collaborative platforms enable
discoveries that would not be possible through individual investigations.
Overall, we believe that this plan for the DMBC oﬀers a broad and solid foundation on which our Center’s data
generation, data modeling, and biological discovery activities can build.